Lymph node stromal cells coordinate immune cell environments during Aspergillus fumigatus infection

Project Summary
The opportunistic fungal pathogen Aspergillus fumigatus presents a major health concern in immunodeficient
and critically ill patients, with invasive disease contributing to high mortality rates. Infection with A. fumigatus
elicits a diverse adaptive CD4 T cell response. Our preliminary data have demonstrated distinct TH1 and TH17
spatial neighborhoods within mediastinal lymph nodes (LNs) during A. fumigatus airway infection. This spatial
organization positions activated CD4 T cells to receive tailored signals (e.g., antigens, cytokines) for optimal
effector cell differentiation and function. Lymph node stromal cells (LNSCs) are known to provide guidance cues
for immune cell trafficking during monotypic effector T cell responses. However, the mechanisms by which
distinct TH1 and TH17 microenvironments are concurrently established within LNs remain unknown. Defining
these mechanisms will offer insights into the functional importance of LN microenvironments in establishing
human immunity to infection and inflammatory disorders for the identification of novel therapeutic strategies.
Based upon our single-cell RNA-sequencing and flow cytometric analyses of FRC and effector T cell subsets
during A. fumigatus challenge, we propose that (i) FRC subsets establish spatially distinct TH1 and TH17
neighborhoods by dynamically regulating chemotactic receptor-ligand axes, such as
CXCR3:CXCL9/CXCL10 and CCR6:CCL20 and that ii) these neighborhoods can persist after pathogen
clearance. We will address these hypotheses in a clinically relevant murine model of invasive pulmonary
aspergillosis. In Specific Aim 1, we will characterize distinct spatiotemporal microenvironments formed by CD4
T cells and FRCs in A. fumigatus infection by applying spatial transcriptomic profiling followed by high-content
immunofluorescence methods paired with a novel computational approach for image analysis. In Specific Aim
2, we will define the functional role of CD4 T cell spatial organization in A. fumigatus infection by perturbing FRC-
dependent chemokine gradients in a cell type-dependent manner using FRC-specific gene targeting. We will
also conduct adoptive co-transfers of A. fumigatus-specific CD4 T cells sufficient and deficient in CXCR3 and
CCR6. In Specific Aim 3, we will investigate the durability of infection-driven spatial FRC diversity by studying
epigenetic modifications in A. fumigatus-experienced FRCs. We will also employ high-content confocal imaging
to determine whether prior infections affect FRC formation of T cell neighborhoods in subsequent infections. This
study employs and develops novel genetic tools, microscopy methods, and computational approaches to
generate a systems level understanding of secondary lymphoid organ immunobiology. Furthermore, this
proposal is tailored for a physician-scientist in training as it investigates the mechanisms by which stromal cells
induce adaptive immunity to the clinically relevant pathogen A. fumigatus, with implications for anti-fungal
therapeutic strategies and vaccine development.

Public health relevance
Project Narrative The opportunistic fungal pathogen Aspergillus fumigatus poses an increasing health concern for critically ill and immunodeficient patients due to widespread anti-microbial resistance. This proposal seeks to investigate the role of lymph node stromal cells in organizing spatial niches for generating diverse adaptive immune responses to A. fumigatus. Understanding the mechanisms by which lymph node stromal cells orchestrate protective immunity may identify novel strategies for development of therapies and vaccines to mitigate the burden of A. fumigatus and other fungal pathogens.